Comparison of Tirzepatide, Retatrutide, and Crocetin, for Mitigation of Alzheimer's-like Pathology in a Mouse Model of Alzheimer’s Disease

PROJECT SUMMARY
The relationship between Type 2 Diabetes Mellitus (T2DM) and Alzheimer's disease (AD) underscores a
pressing need for novel therapeutic interventions to mitigate the underlying pathologies and reduce cognitive
decline. While current treatments for AD primarily target symptomatic relief without modifying disease processes,
recent developments suggest that antidiabetic drugs used to treat T2DM could hold promise in mitigating AD
development. The incretin class of antidiabetic drugs, particularly GLP-1 agonists (e.g. semaglutide, liraglutide),
have shown efficacy in treating T2DM while also demonstrating neuroprotective effects in both humans and
animal models of AD. However, newer compounds like tirzepatide (“twincretin”, GLP-1 + GIP agonist) and
retatrutide (“triplecretin”, GLP-1 + GIP + glucagon agonist) have yet to be investigated, despite the likelihood that
they may be more effective given their combined GLP-1 agonism with additional receptor activations.
Additionally, agonism of free fatty acid receptors (FFAR1 and FFAR4; also known as GPR40 and GPR120)
presents another therapeutic avenue, with crocetin, a natural compound, emerging as a dual agonist of GPR40
and GPR120 receptors. Crocetin's multifaceted neuroprotective properties, including anti-inflammatory and
memory-enhancing effects, position it as a potential disease-modifying therapy for AD. To address gaps in
current understanding, the proposed research aims to evaluate the therapeutic potential of tirzepatide,
retatrutide, and crocetin in a clinically relevant animal model of comorbid AD with obesity/prediabetes induced
by a high-fat diet. The experimental design includes sustained consumption of a high fat diet from the age of 4
to 13 months, an 18-week chronic treatment with tirzepatide, retatrutide or crocetin, beginning at 8 months of
age, followed by behavioral testing and neuropathological analyses of the brains post-mortem at ~ 13 months.
The chronological ages of the mice correspond to early adulthood (4 months) and middle age (13 months)
according to Jackson Labs to include the additional risk factor of older age. While it would be ideally to extend
the study to 15 months of age, classified as old by Jackson Labs, our previous experience with the 3xTg-AD
strain indicates that the attrition rate of male mice would preclude their inclusion in this study. By assessing
cognitive-behavioral function, neuropathological changes, and cardiometabolic alterations, this study aims to
elucidate the efficacy of these interventions in mitigating AD-like pathology and cognitive decline. Importantly,
the inclusion of sex as a biological variable acknowledges sex disparities in AD prevalence and progression, as
well as the ability of sex to modulate treatment outcomes, thereby enhancing the translational relevance of the
findings. Ultimately, this research aims to elucidate novel therapeutic targets for AD, particularly in patients with
comorbid metabolic disease, ultimately contributing to the development of more accessible and effective
treatments for these conditions.

Public health relevance
PROJECT NARRATIVE This project aims to investigate whether two new diabetes medications from the incretin class, tirzepatide and retatrutide, could be efficacious treatments for patients at risk for Alzheimer’s disease due to comorbid metabolic disease (i.e. obesity and prediabetes) using a mouse model of this commonly comorbid set of conditions. Additionally, we will explore the potential of crocetin, a ‘natural substance’ found in saffron, as a more affordable treatment option for patients at risk for Alzheimer’s disease due to comorbid metabolic disease (i.e. obesity and prediabetes). This research could provide valuable insights into new treatment approaches for AD, particularly in individuals with type 2 diabetes mellitus.